Developing and Validating a Multi-Dimensional Scale of Sexual Health

Project Summary
Sexual well-being (SW), the cognitive and emotional evaluation of an individual's sexuality, is an important
aspect of overall health and quality of life, yet it is often overlooked in research and clinical practice. Issues
around sexuality may have wide-ranging repercussions, from mental health problems to damaged
interpersonal relationships, psychological distress, risky behaviors, to violence. Despite this, we still know little
about which factors determine SW, and how to measure it. Existing self-report scales are either designed to be
brief, only suitable for certain groups, and/or focus mostly on sexual functioning and the absence of negative
factors such as coercion or sexually-transmitted infections. While this is important, it is not sufficient for optimal
sexual health, which is “a state of physical, emotional, mental and social well-being related to sexuality;[...]not
merely the absence of disease, dysfunction or infirmity” (WHO, 2006). Optimal SW may also encompass
positive factors, such as feeling loved by one's partner, the ability to enjoy pleasurable experiences, and self-
acceptance. Challenges in measuring SW hinders the research process, making informed decisions on
sexuality education, and the development of impactful interventions. Here we address these gaps by
developing a comprehensive model and in-depth scale of SW which includes positive, strength-based aspects
of sexuality. Our team includes experts in sexuality, public health, psychology, and measurement scale
development. We will use a proven, highly rigorous three-phase methodology over a five year project timeline.
In phase one, we will identify all potential dimensions of SW by applying surveys, analyzing focus groups,
conducting interviews, literature review, and more. Phase two focuses on validation of the identified
dimensions and development of a robust SW measurement scale. We will first generate a pool of
questionnaire items that cover all candidate dimensions and then use interviews, expert feedback, and pilot
studies to refine them. Subsequently, we will conduct large-scale studies with thousands of participants to
establish the scale's dimensionality using factor analysis, and will test scale validity across different subgroups
of our samples. In the final phase, we will assess the value of the resulting SW scale for research and public
health by administering it to 3000 participants in a U.S. nationally representative probability sample. We will
examine how SW dimensions vary with age, gender, and other demographic variables, as well as associations
with health and well-being. Participants will also rate the importance of each dimension, as individuals differ
vastly in what they care about in sexuality. We will test whether incorporating importance ratings into scale item
weights improve its ability to predict health outcomes. Ultimately, our research will deliver a robust SW scale
with demonstrable value for predicting health outcomes, thereby laying a robust foundation for future
investigations, clinical applications, and interventions.

Public health relevance
Narrative This project investigates sexual well-being, a crucial yet often overlooked element of overall health and well- being. By developing a comprehensive model and self-report scale of sexual well-being, we aim to substantially improve our understanding and measurement of this important life domain, thereby paving the way for more effective research, interventions, policies, and education. This could have implications for reducing sexual violence and risk-taking while fostering healthy relationships and improving mental health.